Harnessing engineered drug-free polymeric nanoformulations to reprogram innate immune cells for spinal trauma

Project Summary/Abstract
The endogenous tissue regeneration after traumatic spinal cord injury (SCI) is limited due to an inhibitory
environment by secondary biological events including inflammatory responses. These events result in neural cell
death and demyelination leading to various inflammation-mediated disorders. The long-term goal of this study is
to develop effective acute intervention strategies that limit secondary injuries, thereby creating a permissive
environment that supports regeneration. To achieve this goal, polymer based-nanoparticle (NP) formulations will
be employed to reprogram the circulating innate cells in the blood after trauma. The scientific premise of the
proposed research is based on preliminary data demonstrating that intravenously administered NPs target the
pro-inflammatory sub-set of immune cells prior to extravasation to the injury and reprogram their trafficking
patterns and phenotypes that limit inflammation and additional tissue damage, thereby inducing enhanced
regeneration. Particularly, the immunomodulation is mediated by the physicochemical properties of NPs,
indicating that NPs functions can be engineered differently to influence immune trafficking and phenotypes. The
proposed engineered-NP formulations differentially reprogram innate cells, specifically immunomodulatory
effects of NPs are sex-dependent and, importantly, these effects are solely mediated by distinctive
physicochemical properties of NPs without the active biologics that can cause unfavorable off-target effects. In
this proposal, key physicochemical parameters of NP formulations will be identified for effective
immunomodulation in males and females respectively since the differences in physiological factors between
sexes play a critical role in inflammation after spinal trauma. Aim 1 will focus on interactions between different
NP formulations and innate cells in circulation to identify more effective NP design factors that limit inflammation
in both sexes. Distinct physicochemical properties of NPs will differently affect innate cells trafficking and
phenotype, which will be sex-dependent and subsequently, reprogram an inhibitory environment. NP-induced
differential cellular internalization, phenotype, activation, pharmacokinetic profiles as well as biodistribution of
NPs will be investigated. Aim 2 will investigate the long-term impacts of NPs on anatomical and functional
regeneration after SCI with a more focused set of NP formulations based on Aim 1. Initially, NP-associated
immune cells will be investigated, then the extent of axonal regrowth and remyelination, synaptogenesis, and
functional recovery in the chronic phase of SCI will be assessed. Collectively, the proposed studies will have the
potential to be a transformational therapy by identifying the relationship between physicochemical parameters
and immune modulation for effective NP formulations to support regeneration. Notably, NPs are made of FDAapproved
polymeric biomaterial enabling them to be readily stored for immediate administration non-invasively
as a means to modulate the innate immune system for functional enhancement.

Public health relevance
Project Narrative Tissue regeneration after spinal cord trauma is limited by additional biological events including inflammation, which induce an inhibitory local microenvironment leading to cellular death and functional deficits. lmmunotherapeutic nanoparticles with different physicochemical factors without using active pharmaceutical ingredients interact with circulating immune cells and reprogram their function to mitigate inflammation and modify the microenvironment in favor of regeneration. The proposed studies will identify crucial parameters of nanoparticles for the development of effective nanotherapeutics which will contribute to the development of potentially effective practical therapy for spinal cord trauma.